CRCNS: Waste-clearance flows in the brain measured using physics-informed neural network

The brain’s transport system for cerebrospinal and interstitial
fluid, the glymphatic system, was first described in 2012 by the Nedergaard team, operates primarily
during sleep, and has been linked to pathological neurological conditions including Alzheimer’s disease,
traumatic brain injury (TBI), and stroke. Obtaining quantitative measurements of glymphatic fluid velocity
and pressure is crucial to understanding the function, failures, and potential rehabilitation of the
glymphatic system. However, existing techniques for obtaining in vivo glymphatic velocities are limited to
sparse measurements and specific regions, and pressure variation is essentially impossible to measure
in vivo. We propose to quantify glymphatic flows from measurements of tracked particles and contrast
agents using physics-informed neural networks (PINNs), which can infer velocity and pressure from
sparse measurements and have not been used previously in neuroscience. We will adapt PINNs for
three commonly-employed glymphatic imaging modalities: two-photon perivascular space imaging,
transcranial whole-brain imaging, and dynamic contrast-enhanced magnetic resonance imaging (DCEMRI).
For these modalities, each of which can probe different regions and scales of glymphatic flows, we
will adapt the PINNs equations and artificial intelligence hyperparameters, evaluate the sensitivity of the
approach to noise, spatiotemporal resolution, and imaging artifacts using synthetic data, and validate by
comparing velocities inferred by PINNs to velocities from alternative techniques. Using PINNs will allow
us to obtain in vivo velocity and pressure measurements of cerebrospinal fluid in previously unmeasured
regions of the brain. Our collaborative team of neuroscientists, fluid dynamicists, and applied
mathematicians includes the leaders who discovered the glymphatic system and invented PINNs.
Moreover, we have extensive experience with all three imaging modalities and with velocity
measurement (via automated particle tracking and front tracking) in glymphatic flows.
This proposal seeks to reveal mechanisms by which the brain's transport system for cerebrospinal and
interstitial fluid operates. Our novel velocity and pressure measurements of intracranial cerebral spinal
fluid flows may demonstrate how improving sleep, the state during which the glymphatic system
primarily operates, can counteract pathological processes related to glymphatic system failure including
Alzheimer's disease.